Advanced Microscopy Shared Resource

PROJECT SUMMARY: ADVANCED MICROSCOPY SHARED RESOURCE
The UNMC Advanced Microscopy Core Facility (UAMCF) at the University of Nebraska Medical Center is
dedicated to providing top-notch microscopy and imaging services for competitive fees. The UAMCF was
launched in August 2014 to replace the previous campus microscopy core facility (Confocal Laser Scanning
Microscopy Facility: CLSMF) with the goal of acquiring super-resolution microscopy capabilities on campus.
UAMCF currently provides users with access to a dual-platform super-resolution microscope with capabilities
for super-resolution Structured Illumination Microscopy (sr-SIM) and single molecule Photoactivatible
Localization Microscopy/direct Stochastic Optical Reconstruction Microscopy. Sr-SIM capabilities include up to
100 nm resolution in the x/y axis, and ~300 nm axial resolution. PALM/dSTORM capabilities include single
molecule imaging and precision of ~5 nm coupled with ~10 nm Nyquiste Resolution. In addition, two recent-
model Zeiss confocal microscopes, fully equipped for live image analysis and complete with adjacent
workstations are also available. The Zeiss LSM 800 confocal microscope also has an Airyscan unit for
enhanced resolution that approaches that of sr-SIM imaging. The facility provides outstanding service including
consultations by active researchers with expertise who have published studies using advanced microscopy
techniques. In addition, a Zeiss Cell Discoverer 7 microscope is available for a variety of automated studies.
Finally, the facility also boasts a complete Imaris workstation for advanced 3D imaging processing and
quantification. Overall, the UAMCF provides outstanding support for Cancer Center members and other
researchers on and off campus.